Exploring the interrelationships of mineral metabolism pathways in kidney disease

DESCRIPTION (provided by applicant): In the early stages of my fellowship training in nephrology, I began working with Dr. Darryl Quarles to investigate the role of fibroblast growth factor 23 (FGF23) in phosphate and vitamin D homeostasis. Since these early days in the lab, mineral metabolism has remained my primary area of interest, and I have developed a clear vision of my long-term research and career goals within this field. My career plan is to become a successful independent investigator using basic science methodology to perform translational research aimed at defining the role of aberrant mineral metabolism as a contributor to the co-morbidities associated with progressive kidney disease. I believe the time I have dedicated to performing bench research, combined with the knowledge I have gained through my previous work investigating the role of FGF23 in mineral metabolism, has laid the groundwork for the realization of this long-term goal. There is emerging evidence that FGF23 is important in the pathogenesis of chronic kidney disease-mineral and bone disorder (CKD-MBD). The preliminary work that I have outlined in this application has focused on defining the pathogenesis of CKD-MBD in the context of FGF23 regulation and function. We postulate that early increments of FGF23 from bone are an inciting event which contributes to the development of mineral metabolism abnormalities in this setting. We believe that CKD does not represent a true vitamin D deficient state resulting from renal injury, rather suppression of 1,25(OH)2D production by elevated FGF23 is an adaptive response to maintain neutral phosphate balance in the setting of progressive nephron loss. To elucidate the regulation and function of FGF23 in CKD, we have obtained a genetically altered mouse model of CKD (Col4a3 null mouse) and extensively characterized the bone and mineral metabolism phenotype of this model. Our findings thus far have supported the use of this mouse strain as a model of CKD-MBD found in humans. In this model, mineral metabolism pathways can be altered in a controlled environment to gain insight into the interrelationships and tissue specific effects of individual mineral metabolism pathways. In this proposal, we plan to investigate the impact of several interventions aimed at preventing the natural progression of mineral metabolism changes in CKD. Our specific manipulations will include: 1) the prevention of hyperphosphatemia with phosphate restriction, 2) early calcitriol therapy to counteract the progressive development of 1,25(OH)2D deficiency, 3) early calcimimetic therapy to prevent the development of secondary hyperparathyroidism, 4) the administration of FGF23-deactivating antibodies to lower active circulating FGF23 levels, and 5) the over-expression of klotho to prevent decrements in renal klotho expression. These studies will lead to new knowledge of a complex systems biology that has evolved to permit cross-talk between bone and kidney to coordinate phosphate balance, vitamin D metabolism and bone mineralization. Such knowledge will help us understand and better manage disordered mineral metabolism in patients with CKD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Fibroblast growth factor 23 (FGF23) is a novel hormone that has been found to regulate phosphorus and vitamin D levels in the body, and it is extremely elevated in patients with kidney disease. The discovery of this hormone has changed our thinking regarding the origins of mineral metabolism abnormalities in patients with chronic kidney disease. We plan to use a mouse model of progressive kidney disease to investigate the complex interrelationships of mineral metabolism pathways and to identify the specific contributions of these pathways to the vascular and bone co-morbidities that are common in this setting. Project Narrative Fibroblast growth factor 23 (FGF23) is a novel hormone that has been found to regulate phosphorus and vitamin D levels in the body, and it is extremely elevated in patients with kidney disease. The discovery of this hormone has changed our thinking regarding the origins of mineral metabolism abnormalities in patients with chronic kidney disease. We plan to use a mouse model of progressive kidney disease to investigate the complex interrelationships of mineral metabolism pathways and to identify the specific contributions of these pathways to the vascular and bone co-morbidities that are common in this setting. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The discovery of fibroblast growth factor 23 (FGF23) and its marked elevation in chronic kidney disease (CKD) has changed the way we view mineral metabolism in this setting. We propose that the elevation of this hormone is an early biomarker of disordered mineral metabolism and is an important adaptive response that helps maintain phosphate homeostasis during progressive CKD both by increasing the fractional excretion of phosphate and suppressing 1,25-vitamin D production. However, as kidney disease progresses we suspect that the elevations in FGF23 become maladaptive and contribute to the excessive morbidity and mortality associated with end stage renal disease (ESRD). A recent study linking elevations of FGF23 with increased mortality in a large ESRD population seems to support this theory (1). Due to the complex interrelationships that exist between PTH, 1,25(OH)2D, FGF23, calcium and phosphorus in CKD, controlled studies evaluating the effects of current therapies on these markers is difficult in humans. There is a need for a reliable system in which the tissue-specific effects of our current therapies for abnormalities in mineral metabolism can be systematically tested and the complex interrelationships of these pathways can be deciphered in an in vivo setting. Our preliminary work has focused on extensively characterizing the mineral metabolism phenotype of the Col4a3 null mouse model and defining this mouse strain as a model of CKD-mineral & bone disorder (CKD- MBD). To define the complex interrelationships of mineral metabolism pathways in CKD and test the impact of current and novel treatment strategies on the development of CKD mineral & bone disorders (CKD-MBD), we plan to: 1. Examine the effect of current treatment strategies on FGF23 levels and the relative impact on other markers of mineral metabolism, CKD progression, associated co-morbidities and mortality in the Col4a3-/- mouse model. Specific studies will investigate: a. The effect of early phosphate restriction b. The impact of early calcitriol administration c. The effect of early PTH suppression with calcimimetic therapy 2. Investigate the molecular pathways that regulate FGF23 production in CKD and explore potential mechanisms for the observed association between increased morbidity/mortality and elevated FGF23 levels in this setting. We will accomplish this aim by altering FGF23 signaling in the Col4a3-/- mouse model using two methods and identifying the associated tissue changes and phenotype. We plan to: a. Neutralize circulating FGF23 with FGF23-deactivating antibodies in early and late CKD b. Prevent the progressive decline in renal klotho expression that occurs in CKD by crossing the Col4a3-/- mouse to a transgenic mouse of klotho over-expression